Adaptations of Brain Energy Metabolism to Hypoglycemia

DESCRIPTION (provided by applicant): Diabetic complications can be reduced by normalization of blood glucose levels via intensive insulin therapy. This treatment, while effective, bears the risk of an increased incidence of recurrent hypoglycemia. It blunts the central counterregulatory response to low blood glucose (counterregulatory failure) and thereby magnifies the risk of severe hypoglycemia and brain injury. The overall goal of this proposal is to understand the changes in brain metabolism that underlie these phenomena and identify possible therapies in order to prevent them. We will determine the impact of a medium chain fatty acid enriched diet on brain metabolism in tightly controlled T1DM subjects with hypoglycemia unawareness and an animal model thereof. We will further test the hypothesis that chronic provision of medium chain fatty acids can improve cognitive performance under hypoglycemia in human subjects. Data gathered from our animal studies revealed a specific change of neuronal energy metabolism under hypoglycemia following exposure to antecedent recurrent hypoglycemia that make is more difficult for neurons to utilize fuels like glucose or lactate. We also found that after recurrent hypoglycemia, lactate uptake into the brain was facilitated, but because it could subsequently not be utilized by mitochondria as effectively as under control conditions, it may not be an ideal fuel. This let us to look for different alternate substrates that follow the same route of uptake as lactate, but enter metabolism via a different pathway. One group of fuels that fulfill these criteria are ketone bodies and medium chain fatty acids. Applying state of the art technologies like in vivo NMR spectroscopy to our animal model of recurrent hypoglycemia will allows us address the hypothesis that they are better suited to support metabolism. We will use this animal model to determine how diabetes confounds the adaptations induced by recurrent hypoglycemia alone and then go on to translate our findings to a clinical study of cognition and metabolism in intensively treated T1DM patients. Our work is the first step towards developing candidate molecules into novel therapies that would protect the brain from hypoglycemia induced brain injury. The projects proposed here are building on preliminary studies that I have performed during my NRSA fellowship training and since then. They will give me the ideal opportunity to continue my training in NMR spectroscopy and its application to neuroscience and diabetes related complications. Most of my training thus far has been in the use of basic science methods and animal models. Wanting to become a well trained physician scientist however I realized that I still needed more training in human investigation. To that end I enrolled in a Master of Health Sciences program to receive further training in translational methods. Funding under this career award will allow me to continue these activities and give me the protected time from clinical duties that I will need to accomplish my career goal of establishing myself as an independently funded physician-scientist, eventually with my own laboratory and workgroup.

Public health relevance
PUBLIC HEALTH RELEVANCE: Understanding the changes of brain energy substrate transport and metabolism in intensively treated type 1 diabetic patients will provide the basis for the identification of novel therapeutic approaches that could protect the brain from hypoglycemia induced injury. This in turn could then sustain normal brain metabolism under hypoglycemia and would also allow for tighter glucose control with better protection from long-term diabetic related complications. Project Narrative Understanding the changes of brain energy substrate transport and metabolism in intensively treated type 1 diabetic patients will provide the basis for the identification of novel therapeutic approaches that could protect the brain from hypoglycemia induced injury. This in turn could then sustain normal brain metabolism under hypoglycemia and would also allow for tighter glucose control with better protection from long-term diabetic related complicaitons. __SpecificAimsTextDelimiter__ Specific Aims Maintaining plasma glucose at near normal levels via intensive insulin therapy in type 1 diabetes (TIDM) markedly reduces the risk for developing long-term microvascular and macrovascular complications [1]. However, intensive insulin therapy increases the risk of severe and recurrent hypoglycemia, which can cause rapid deterioration of cognitive function and often occurs without warning symptoms [2]. As a result, hypoglycemia limits the ability of patients to achieve target glycemic goals because the immediate fear of hypoglycemia often exceeds the fear of long-term complications. Therefore, new strategies to protect the brain from hypoglycemia-induced cognitive impairment and injury are essential for optimizing the benefits of insulin therapy for all patients with TIDM. Here we explore the potential of alternate fuels to offer neuroprotection during hypoglycemia and to reduce the cognitive impairment provoked by severe hypoglycemia. Our proposal is based on strong preliminary data from animal and clinical studies using NMR spectroscopy that show that antecedent exposure to hypoglycemia shifts the brain's dependence on glucose as the main energy substrate towards the use of alternate substrates. Characterization of this change in energy substrate utilization will allow us the development of new therapies, such as dietary interventions, that can prevent brain injury caused by diabetes, recurrent hypoglycemia or both. With this in mind, the following three specific aims are proposed: Specific Aim 1: To measure neuronal and glial TCA cycle activity in an animal model of T1DM and recurrent hypoglycemia in vivo via NMR spectroscopy using labeled acetate and lactate as substrates. During hypoglycemia, other substrates must take the place of glucose if brain energy failure is to be prevented. We can measure their contributions to brain energy and neurotransmitter metabolism in vivo by carbon-13 NMR spectroscopy using 13C-acetate as a probe. In a study of metabolism, in which we had saturated brain fuel uptake to eliminate its influence on metabolic rates, we found that recurrent hypoglycemia impaired glucose utilization by reducing pyruvate dehydrogenase (PDH) complex activity in neurons. In a follow-up study using 13C-lactate at a physiologic plasma level, however, we observed an increased lactate transport capacity into the brain under hypoglycemia that was able to compensate to some degree for the decrease in neuronal glucose utilization. It is unknown whether similar adaptations occur in an animal model of diabetes, but synergistic effects of hypoglycemia and diabetes are described in other tissues, suggesting an even bigger contribution of alternate fuels to brain metabolism. Hypothesis: Recurrent hypoglycemia in an animal model of T1DM and recurrent hypoglycemia will reduce neuronal glucose utilization, shifting metabolic substrate use towards alternate fuels. We hypothesize that an experimental diabetic state leads to adaptations that try to protect the brain from high ambient glucose levels by reducing its uptake and its metabolism by PDH, an effect that will further magnify the degree of alternate fuel use induced by recurrent hypoglycemia alone. Specific Aim 2: To characterize the metabolic adaptations in the brain produced by a Medium Chain Fatty Acid enriched diet in diabetic rats exposed to recurrent hypoglycemia by in vivo carbon-13 NMR. 13C-acetate as a metabolic probe allows characterization of the effect of chronic (3 week) exposure to dietary MCFAs on neuronal and astrocytic metabolism in an animal model of T1DM and recurrent hypoglycemia. Even though lactate uptake was enhanced after recurrent hypoglycemia, its therapeutic use is limited since it enters the TCA cycle like glucose via PDH. A chronic MCFA-enriched diet has two benefits: a) it induces alternate fuel use in mitochondria to decrease the dependence on glucose as the primary fuel and b) it directly serves as an energy substrate itself and raises plasma ketones, which use the same enhanced transporters as lactate, but don't depend on PDH for further metabolism. Hypothesis: Chronic MCFA therapy will support brain energy metabolism during an acute episode of hypoglycemia by induction of alternate fuel use. We expect the highest degree of shift towards alternate fuel utilization in the T1DM- recurrent hypoglycemia- MCFA diet group. This opens up new therapeutic avenues to reduce the impact of hypoglycemia on brain function in humans. Specific Aim 3: To determine the effect of a 6-wk MCFA-supplemented, reduced carbohydrate diet on cognitive performance and brain metabolism during a standardized acute hypoglycemic stimulus in intensively treated TIDM subjects. To measure the relationship between alternate fuel metabolism and cognition, under hypoglycemia, subjects on the MCFA enriched and control diet will undergo cognitive testing and receive an MCFA infusion (13C-octanoate) during an NMR scan. Secondary end-point measures include the effects of a MCFA-supplemented reduced carbohydrate diet on glucose control, postprandial glucose excursions, hypoglycemia episodes, and counterregulatory hormone responses to acute hypoglycemia. Hypothesis: A 6-wk, MCFA supplemented, reduced carbohydrate diet will reduce cognitive dysfunction in intensively-treated T1DM patients during acute hypoglycemia. Following dietary exposure octanoate will be able to support a major proportion of brain oxidative capacity. The MCFA diet will have the secondary benefits of reduced postprandial hyperglycemia and insulin requirements, without increasing the risk of hypoglycemia or the threshold for initiating the counterregulatory responses.